Characterization of T cells in MOG antibody-associated disease

PROJECT SUMMARY / ABSTRACT
Myelin oligodendrocyte glycoprotein (MOG) has been recognized as an autoantigen (autoAg) in EAE and as
a putative T cell and antibody (Ab) target in MS. Recently, MOG has been identified as the target in several CNS
autoimmune conditions, including acute disseminated encephalomyelitis (ADEM), optic neuritis (ON), and
transverse myelitis (TM). Collectively, this spectrum is known as MOG Ab-associated disease (MOGAD).
Currently, there are no FDA-approved treatments for MOGAD. Key aspects regarding MOGAD pathogenesis
have not been elucidated. MOG-specific Abs in MOGAD are T cell-dependent and are not pathogenic in the
absence of T cell-mediated CNS inflammation. Therefore, we hypothesize that MOG-specific T cells have a
central role in MOGAD and cooperate with B cells, and possibly MOG-specific Abs, to promote CNS injury.
MOG-induced EAE is an invaluable model to evaluate how MOG-specific T cells cooperate with MOG-
specific B cells and Abs in MOGAD. Like MOGAD, MOG-induced EAE manifests as ON, TM and
encephalomyelitis. Besides serving as a source of MOG-specific Abs, B cells are Ag presenting cells (APC). EAE
induction by MOG protein is B cell MHC II-dependent. Whether B cell Ag presentation promotes development
of a distinct pathogenic T cell repertoire is unknown. We hypothesize that B cell Ag presentation expands a unique
TCRa/b repertoire of MOG-specific pathogenic T cells. Susceptibility to MOG protein-induced EAE is sensitive
to certain human-specific amino acid (aa) sequence differences. Novel MOG T cell epitopes identified from
studying MOGAD patients are located within the region where many aa sequence differences are clustered. To
understand cellular and humoral responses to human MOG, and to better translate our findings, we created
humanized MOG knock-in mice by replacing mouse MOG genomic sequence with human genomic MOG.
In this program, we propose: (1) To identify and characterize MOG-specific T cells in patients with distinct
MOGAD phenotypes. Peripheral blood mononuclear cells will be collected from patients enrolled at three
collaborating institutions. MOG specificity will be determined by stimulation with overlapping MOG peptides
and TCRa/b repertoire will be examined by single cell RNA sequencing (scRNA-Seq). (2) In subaim 2a we will
determine how B cell Ag presentation in vivo may shape development of the pathogenic MOG-specific T cell
repertoire. T cells from wild-type, B cell-deficient and MOG-specific B cell receptor (BCR) mice immunized
with MOG protein (B cell-dependent) or MOG peptide (B cell-independent) will be subjected to TCRa/b repertoire
analysis by scRNA-Seq. In subaim 2b, our humanized MOG mice will be characterized for MOG-specific T cell
and humoral responses, and requirement for B cell-T cell cooperation in EAE. Serum MOG-specific Abs from
MOGAD patients will also be tested for pathogenic potential in recipient humanized MOG mice.
Our results should provide invaluable knowledge regarding MOGAD pathogenesis and insights regarding B-
T cooperation in MOGAD and other organ-specific autoimmune diseases.

Public health relevance
PROJECT NARRATIVE Myelin oligodendrocyte glycoprotein (MOG) antibody-associated disease (MOGAD) was recently recognized as a spectrum of central nervous system inflammatory conditions that are separate from multiple sclerosis (MS) and neuromyelitis optica spectrum disorder (NMOSD). Research indicates that MOG-specific T cells have a central role in the pathogenesis of MOGAD, yet there is essentially no knowledge regarding MOG-specific T cells in MOGAD. The goal of this project is to identify and characterize MOG-specific T cells in MOGAD, and by using a model of MOGAD, to determine how MOG-specific T cells and B cells cooperate to cause MOGAD.